Coordination of high fidelity replication with mutagenic translesion synthesis

ABSTRACT
Failure to properly coordinate DNA replication with repair and potentially mutagenic translesion DNA synthesis
(TLS) contributes to mutations that underlie numerous human disease states, including cancers, as well as
antibiotic resistance and adaptation of clinically significant microbial pathogens. We use Escherichia coli as a
model to define fundamental mechanisms by which organisms mange the actions of their high fidelity
replicative DNA polymerase(s) (Pol) with those of low fidelity TLS Pols involved in lesion bypass and
mutagenesis. The process by which one Pol replaces another at a replication fork is referred to as `Pol
switching'. Sliding clamp proteins (DnaN or β in bacteria; PCNA in eukaryotes and archaea) play essential
roles in these switches. The generally accepted `toolbelt' model for Pol switching postulates that two different
Pols simultaneously bind separate hydrophobic clefts in the same β clamp to sequentially access the DNA. In
stark contrast with the toolbelt model, we recently determined that TLS Pols interact with each other and with
the Pol III replicase, and while the mechanistic contributions of these interactions are currently unknown, we
nevertheless demonstrated that Pol-Pol interactions are absolutely required for Pol switching in vitro and in
vivo. We have also identified several novel Pol-β clamp interactions important for Pol function. In Aim 1, we will
exploit our structural model of the Pol III-β clamp-Pol IV complex, as well as a wealth of biochemical,
biophysical, single molecule and genetic approaches to define for the first time in molecular detail the specific
contributions to switching of discrete Pol III-Pol IV and Pol IV-β clamp interactions. In Aim 2 we will exploit
structural insights we have gained regarding the Pol II-β clamp complex to define in molecular detail how the β
clamp manages Pol II processivity, proofreading and Pol III-Pol II and Pol II-Pol IV switching. In Aim 3, we will
use small angle X-ray scattering (SAXS), cryo-electron microscopy (cryo-EM), molecular modeling and a
combination of biochemical and biophysical approaches to structurally define how the different Pols interact
with each other and the β clamp, and how DNA influences these interactions. In addition, we will determine
the protein stoichiometry of the different Pol-β clamp and Pol-β clamp-Pol complexes using size exclusion
chromatography coupled with multi angle light scattering (SEC-MALS), which Pols interact with each other,
and whether or not these interactions are competitive. Taken together, results of these studies will provide
unprecedented insight into the molecular mechanisms by which E. coli manages and coordinately regulates
the actions of its different Pols during DNA replication, repair and TLS. Finally, our findings may identify critical
steps in these higher order regulatory networks that generalize to other bacteria and can be targeted by
chemotherapeutics to control replication and mutagenesis.

Public health relevance
PROJECT NARRATIVE Mutations contribute directly to human diseases, including cancers; they also complicate treatment of individuals infected with microbial pathogens by conferring antibiotic resistance and adaptation of these pathogens to their human host. We will define mechanisms by which low fidelity E. coli DNA polymerases gain access to the replication fork to catalyze mutations. We anticipate that our results will identify critical features of these mechanisms that can be targeted to control bacterial replication and its fidelity for therapeutic gain, and will serve as a framework for understanding similar control networks in other organisms, including humans.